Administrative Core

Project Abstract-Summary (Administrative Core)
The Administrative Core of the University of Michigan Molecularly Targeted Radiosensitization
of Locally Advanced Cancers SPORE (Radiosensitization SPORE) supports all projects, cores,
and developmental programs of the SPORE. The SPORE has well-defined and interactive
organizational structure that includes clearly defined leadership and advisory capabilities
organizational structure serves to meet the specific aims of the SPORE, especially to facilitate
high-impact and innovative research opportunities with minimal barriers and maximal flexibility,
while ensuring accountability and transparency in scientific and budgetary decisions. The
Administrative Core fosters in-depth communication among all SPORE components to enhance
research integration, provide critical scientific feedback, evaluate scientific progress, plan for
future opportunities, and assert translational focus.

Public health relevance
PROJECT NARRATIVE (ADMINISTRATIVE CORE) Through its interactive organizational structure including clearly defined leadership and advisory capabilities the Administrative Core of the University of Michigan Radiosensitization SPORE supports all projects, cores, and developmental programs of the SPORE. The Administrative Core fosters in-depth communication among all SPORE components to enhance research integration, provide critical scientific feedback, evaluate scientific progress, plan for future opportunities, and assert translational focus. The Core communicates with the National Cancer Institute staff and helps its scientists disseminate their findings rapidly to the public.